NYS AGM Food Laboratory Discipline Microbiology, Analytical Track 4 - Whole Genome Sequencing - July 1, 2020 - June 30, 2025

NY AGM Food Laboratory - Project Summary/Abstract: The New York State Department of Agriculture and Markets (NY AGM) has an expansive and robust food safety inspection program and a regulatory food safety testing laboratory. The Food Laboratory, a division within the NY AGM, has a mission to provide expert state of the art analytical testing in support of food safety programs in New York State. The Food Laboratory, through food testing, provides support to the divisions of Food Safety and Inspection, and Milk Control and Dairy Services. It is the primary servicing laboratory for the New York manufactured food regulatory program and is accredited to the ISO/IEC 17025 standard. The Food Laboratory has comprehensive testing programs for foodborne pathogens in human food. If funded for Microbiology Discipline and Analytical Track 4 – Whole Genome Sequencing, the Food Laboratory will maintain the Research Collaboration Agreement with CFSAN for the GenomeTrakr network. It will continue to sequence a mixture of four hundred (400) or more foodborne related bacterial isolates and parasites in real-time coordination with FDA CFSAN, and deposit results, including the metadata, in to the NCBI-NIH curated national database. It will also seek partnership with universities, government agencies, and other stakeholders to support the collection of isolates. Additionally, the Food Laboratory key personnel will attend mandatory meetings such as GenomeTrakr annual conference. The NY AGM fully supports FDA’s initiative of enhance the GenomeTrakr network by capturing the current and evolving genomic diversity of non-clinical pathogens across FDA-relevant areas in human or animal food, environmental, and water samples.